Fungal dysbiosis regulation of post-influenza bacterial pneumonia

Project summary
The discovery of antibiotics in the early 20th century opened up a new era of medical treatment. Indeed, many
present-day infections that are easily treated could have had deadly consequences in the absence of antibiotics.
The overuse of these medicines has been a concern in the recent years due to the selection pressures that have
allowed resistant bacterial species to emerge. However, another untoward consequence of antibiotics is that
treatment can alter the commensal organisms of the body, which we now understand has important homeostatic
functions. Indeed, many bacterial, fungal, and viral organisms that live within tissues of the body can condition
the immunologic system, and an altered microbiome, such as with antibiotic use, can contribute to the
development of many acute and chronic pathologies. As such, our studies demonstrate that giving prophylactic
antibiotics during influenza infection (a common clinical practice) increases the risk for development of a
secondary bacterial pneumonia, which is major reason for the morbidity and mortality from the initial viral illness.
Although antibiotics have direct effects on decreasing the abundance and diversity of the bacterial microbiome,
the newly available niche with reduced nutritional competition provides an opportunity for expansion of fungal
communities. Our data demonstrates that fungal dysbiosis is a driver of worsened secondary bacteria pneumonia
after influenza infection. Moreover, we find that antibiotic-induced fungal dysbiosis increases lung inflammation
including augmented interferon-γ levels, a cytokine that can clear detrimental effects that contribute to post-
influenza bacterial pneumonia. Finally, we find that eosinophils partially modulate the augmented lung injury,
and increased gut S. cerevisiae correlates with the phenotype induced by fungal dysbiosis. Altogether, these
findings support our central hypothesis that antibiotic treatment during influenza infection causes fungal dysbiosis
that has lung immunomodulatory effects, which in turn increases the host susceptibility to bacterial
superinfection. We will test this hypothesis in the following aims:
Aim 1. Determine if fungal dysbiosis alters innate immune functions in post-influenza pneumonia.
Aim 2. Evaluate how fungal dysbiosis causes lung eosinophilia to augment lung inflammation.
Aim 3. Investigate the role of S. cerevisiae in mediating lung injury from post-influenza MRSA pneumonia.

Public health relevance
Project narrative Influenza infection is a deadly disease that is often complicated by a secondary bacterial pneumonia, which is a significant contributor to the morbidity and mortality. Antibiotics do not help the viral illness, and our work demonstrates it causes harm by altering the commensal organisms in the gastrointestinal tract to increase the susceptibility to bacterial pathogens. This study will understand how antibiotics altered the fungal colonies in the gut that affect the lungs immunity to pathogens and aim to lead to novel therapeutics that can target the mediators of this effect.